2023 Collective Behavior Gordon Research Conference

Project Summary
Collective behaviors are social and coordinated processes that arise spontaneously in all kingdoms of life.
They can be observed in a variety of contexts: the blinking of fireflies, the marching of an army of locusts, the
schooling of fish, the aggregation of social bacteria, and viral attacks. They are even observed in the movement
of inanimate objects, such as robot swarms. Collective behaviors occur on all scales of living systems;
synchronous behaviors extend from the organism to the tissue, to the cell, to the molecule. Ironically, research
on collective behaviors is not coordinated. Disparate scientific groups work on these phenomena in many
disciplines, including evolutionary biology, microbiology, mathematics, physics, and engineering. Although the
problems being pursued have exciting overlaps, interaction between groups has been sparse. We propose three
steps to create a unified and enduring research community committed to the study of collective behavior by
providing trans-disciplinary bridges: (1) build a trans-disciplinary community of collective behavior researchers
by holding a biannual Gordon Research Conference (GRC) on Collective Behavior, (2) build an enduring
inclusive trans-disciplinary community of collective behavior researchers based around this GRC by recruiting
participants from under-represented groups; and 3) establish a permanent venue for the GRC on Collective
Behavior. To begin this community building and to promote this new inter-disciplinary field, we will hold the first
GRC on Collective Behavior August 13 - 18, 2023 at Grand Summit Hotel at Sunday River, Newry, ME.
The goal of this conference is to establish trans-disciplinary collaborations between scientists to share
information, approaches, and technologies in a coordinated effort to transform investigations of collective
behavior. Specifically, we expect the conference will promote the discovery of unifying principles across scales
and organisms and uncover how the findings, both experimental and theoretical, can be used in future
experimentation, computation, robotics, and medical applications. Moreover, the conference will help to further
our understanding of how collective behaviors emerge from the behavior of single components, such as
individuals, cells or molecules.
Sixty-five percent of the invited speakers and discussion leaders (and most likely the attendees) focus their
research on areas that are a high priority for NIBIB. This includes using synthetic and computational biology and
mathematical modeling and simulations to analyze collective behaviors in both animate and inanimate systems.
The researchers in this emerging field of study would be a rich source of new NIBIB investigators. Furthermore,
NIBIB funding, which will supplement travel and registrations costs, is expected to increase the participation of
women, URM postdoctoral fellows and graduate students, and early career investigators, who otherwise could
not afford to attend this conference. We are especially interested in supporting this group of young and diverse
researchers, as they will fuel the future of this new research area of collective behavior.

Public health relevance
Project Narrative Have you ever wondered how flocks of birds and schools of fish synchronize their movements or fireflies blink in unison? These are examples of collective behaviors that can be found in all the domains of life (animals, plants, fungi, bacteria, and viruses) and in the movement of inanimate objects, such as robot swarms. The 2023 Collective Behaviors Gordon Research Conference will explore this emerging discipline spanning many fields including microbiology, ecology, evolutionary biology, theory and computation, engineering, and physics.